Defining the molecular mechanism of gut inflammation and barrier dysfunction in people with HIV (PWH)

ABSTRACT
Substantial diarrhea is noted in about 50% of human immunodeficiency virus (HIV)-infected subjects with or
without antiretroviral therapy (ART) in the U.S., of which the pathogenesis remains unclear. One of the challenges
in studying HIV-associated diarrhea is that these patients often have comorbidities, such as malnutrition and co-
infection with other gut pathogens, and hence it is difficult to dissect out the contributions of each cellular and
microbial pathogenic components and their mechanisms. While a mouse model would provide a clean platform
to study HIV-associated diarrhea, HIV does not infect murine immune cells, thus limiting the development of in
vivo models. We recently established a novel humanized mouse model that supports robust reconstitution of
human innate and adaptive immune systems in both lymphoid and non-lymphoid tissues, which provides an
opportunity to investigate the pathogenesis of HIV enteropathy in vivo. The scientific premise of the findings is
that the humanized mouse model faithfully recapitulates the molecular dynamics of HIV infection in immune cells.
We also discovered that CARD8 inflammasome is activated in by the HIV protease. CARD8 inflammasome has
been implicated in modulating the severity of inflammatory bowel disease (IBD) and inflammasome-mediated
pyroptosis is known to trigger gut inflammation. In the gut, while HIV only infects immune cells (CD4+ T cells and
macrophages), these cells also interact with intestinal epithelial cells (IEC), and could contribute to the
homeostasis of gut barrier integrity. The knowledge gaps for advancing our understanding of HIV enteropathy
are the clinical relevance of HIV infection and/or ART per se on gut barrier function, and if CARD8 inflammasome
also adversely impacts IEC homeostasis. Our overarching hypothesis is that HIV-infected immune cells impede
gut epithelial integrity through pyroptosis induction. We aim to understand the molecular mechanism governing
gut inflammation and barrier leakiness during HIV infection and whether such damage persists despite
suppressive ART, which impairs wound healing during subsequent injuries. We propose to define the interplay
between IEC and HIV-infected immune cells in vitro, to define the how HIV infection dysregulates gut barrier
function under injury using humanized mouse models, and to define the molecular crosstalk between IEC and
immune cells in gut samples from HIV patients. Collectively, we will establish that HIV infection could negatively
impact gut barrier integrity. We will additionally establish that HIV-activated inflammasome mediates the
disruption of get epithelial barrier by recruitment of additional proinflammatory cytokines and chemokines that
target the IEC. Other deliverables will also include the potential of targeting pyroptosis for HIV enteropathy.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to the public health because a substantial number of persons with HIV (PWH) suffer from severe diarrhea, of which the detailed mechanisms remain unknown. As HIV primarily infects immune cells, we hypothesize that HIV-infected immune cells will have enhanced secretion of proinflammatory cytokines and reduced secretion of intestinal epithelial-beneficial growth factors, thus causing gut barrier dysfunction. We will use cutting edge humanized mouse model and gut epithelial stem cell culture system to dissect out the interaction between HIV-infected immune cells and intestinal epithelial cells, thus providing insight into the pathogenesis of HIV enteropathy.